Development and translation of a novel radiotracer to image alpha-1 adrenoceptors using positron emission tomography for use in imaging posttraumatic stress disorder

Successful pharmacological treatment of posttraumatic stress disorder (PTSD) is challenging and remains a
significant unmet need for Veterans, their families, and VA. Excessive noradrenergic (NA) activity has been
identified as an important contributor to PTSD pathology, and prazosin, a non-selective alpha-1 adrenoceptor
(α1 AR) antagonist, has demonstrated effectiveness in reducing PTSD-related nightmares, sleep disturbances,
and dysregulated alcohol use in Veterans and Servicemembers (SMs). Unfortunately, not all Veterans and
SMs tolerate or respond to prazosin therapy for reasons that remain unclear. Biomarkers for measuring brain
NA activity and identifying who will respond to prazosin have been difficult to establish and are not consistently
reliable or easy to implement. Currently, a major limitation to understanding NA system regulation in PTSD and
strategies to improve upon prazosin is the lack of means to image α1 AR in living human brain.
Positron emission tomography (PET) is a non-invasive, translational imaging modality capable of
selectively imaging targets in the central nervous system (CNS) with high specificity and sensitivity. CNS PET
radioligands have provided critical breakthroughs in the understanding of many neuropsychiatric disorders and
have assisted and expedited novel drug development. To date, attempts at developing an α1 AR radiotracer
have failed due to lack of target selectivity, inadequate brain penetrance, and/or high non-specific binding,
yielding images of poor quality that cannot be meaningfully quantified. Members of the pharmaceutical industry
often develop novel CNS PET radiotracers in tandem with therapeutic lead agents, but given the generic status
of prazosin, the motivation for CNS α1 AR radiotracer development outside VA is likely limited.
A series of radiolabeled analogues of a well-described highly selective α1A AR antagonist have shown
promise as novel radiotracers for PET imaging. They exhibit favorable characteristics as CNS PET radiotracers
with high α1A AR affinity, moderate lipophilicity, demonstrated engagement with human brain α1 AR, capability
of imaging α1 AR and its occupancy by prazosin in brain of living rats, low non-specific binding, and lack of
affinity to the permeability-glycoprotein (P-gp) and breast cancer resistance protein (BCRP) drug efflux
transporters at the blood-brain barrier (BBB). However, their use is limited by carbon-11 (radioactive half-life =
20 minutes) which requires production by an on-site cyclotron and limits available imaging time.
A series of compounds based on the promising lead and amenable to labeling with fluorine-18
(radioactive half-life = 109 minutes) will greatly extend their availability and utility. These compounds will be
synthesized with minor modifications consistent with prior PET radiotracers. Using an enhanced high-
throughput radiotracer development pipeline they will be progressively screened to: 1) assess their in vitro
properties by α1 AR binding in human membrane preparation and brain tissue; 2) assess brain entry in rats, α1
AR engagement assessed by prazosin blockade, and P-gp substrate identification by blockade using the P-gp
inhibitor elacridar by means of ex vivo LC-MS/MS; and 3) assess their performance as CNS PET radiotracers
for α1 AR in rats. These assessments will provide a further screening basis for selection of the best performing
candidate, which will be advanced for radiation dosimetry analysis, full CNS target binding, and toxicology
studies prior to an exploratory Investigational New Drug (eIND) submission to the FDA.
The ultimate goal beyond this project is to develop a successful PET radiotracer to quantify α1 AR
receptor availability in human brain, identify PTSD patients responsive to prazosin treatment, and expedite the
development of novel PTSD therapeutics targeting CNS α1 ARs. A radiotracer for imaging α1 AR in human
brain is the only tool capable of non-invasively interrogating prazosin at its site of action and α1 AR regulation
of the CNS noradrenergic system in vivo, providing a direct means for developing novel therapeutic drugs for
treatment of Veterans and Servicemembers with PTSD.

Public health relevance
Exposure to extreme stress, such as life-threatening combat, activates stress-response systems that release a chemical messenger called noradrenaline into the brain and bloodstream. Noradrenaline activates portions of the brain that regulate emotions, alertness, heart rate, blood pressure, and stress hormones in preparation for a fight or flight response by binding to receptors on neurons, a process that is much like inserting a key into the ignition and turning it to start an automobile. Persistent or untimely signaling by noradrenaline is understood to contribute to posttraumatic stress disorder (PTSD) and its symptoms such as difficulty getting or staying asleep, nightmares of threatening events, or heightened alertness to potential threats even when none are present. Prazosin, a drug that blocks noradrenaline from binding to its receptors, can be effective in treating PTSD-associated nightmares. This project seeks to develop a new brain imaging technology that will allow scientists to see where noradrenaline acts in the brain, and hopefully lead to better treatments for PTSD.